Defining the Role of Collagen XII in Regulating Skeletal Muscle and Tendon during Aging

Project Summary
Collagen XII is known to bind to collagen I fibrils to create inter-fibrillar bridges that influence collagen
fibril assembly and organization. Collagen XII also localizes at the cell surface in the pericellular matrix to form
inter-cellular bridges that are critical for establishing cell organization in bone and tendon during development.
Clinically, collagen XII deficiency presents with both features of connective tissue disorders and myopathy, and
similar functional deficits have been recapitulated in a murine model for collagen XII deficiency. Recent work
has established the role of collagen XII in development and injury regeneration in various tissues. However,
despite myopathy appearing in middle-age collagen XII-deficient patients and worsening with age, no work has
been done on aged (post-skeletal maturity) collagen XII-deficient animals to determine what is driving this
clinical pattern. Thus, the mechanisms by which collagen XII regulates muscle-tendon structure and
mechanical function during aging remain unknown. Therefore, our overall goal is to determine the differential
role of collagen XII in the murine muscle-tendon unit in progressing age-associated changes to overall tissue
function and regulating overall tissue function after skeletal maturity. Our global hypothesis is that collagen XII
bridging is necessary for gap junction formation between cells throughout the muscle-tendon unit after
development and that collagen XII mediates matrix interactions that maintain muscle-tendon unit composition,
structure, and function during aging. Using powerful genetic mouse models that allow us to alter the expression
of collagen XII, we will study the following aims: Aim 1: Define the role of collagen XII in cell-cell
communication and ECM remodeling across the murine muscle-tendon unit during aging; Aim 2: Elucidate the
differential roles of collagen XII in determining changes to structure, composition, and function across the
murine muscle-tendon unit during aging. Rigorous, carefully chosen, and well-established structural, functional,
compositional, and biological assays will allow us to define the differential role of collagen XII in
musculoskeletal tissues in the contexts of aging and disease. The activities described by this proposal provide
a strong foundation for scientific inquiry in the fields of musculoskeletal biology and biomechanics, preparing
me to be valuable contributor to these fields as an independent investigator.

Public health relevance
Project Narrative Aging is associated with structural and functional changes to tendon and muscle that affect the way these tissues interact and coordinate the transfer of forces necessary for daily activities. The objective of this proposal is to define the role of collagen XII in contributing to changes in extracellular matrix properties and cellular activity in the muscle-tendon unit during aging. Using gene%c mouse models that allow us to alter collagen XII expression, we will a gain a better mechanistic understanding of how collagen XII contributes to age-associated functional deficits in the muscle-tendon unit and guide future therapeutics to mitigate the increased risk of musculoskeletal injury due to aging and congenital disorders such as myopathic Ehlers- Danlos syndrome.